Early Dyadic Synchrony and Middle Childhood Outcomes Among Infants at Genetic Risk for ADHD or Autism

PROJECT SUMMARY/ABSTRACT
ADHD and autism spectrum disorder (ASD) are two prevalent, heritable neurodevelopmental conditions that
frequently co-occur. Evidence of overlapping genetic risk suggests they may also share developmental pathways
and broader phenotypes. Prospective, genetically-informed, transdiagnostic familial risk designs provide an
opportunity to investigate the interplay between genetic risk and early life experiences that may mitigate or
exacerbate such risk. Parent-infant synchrony during dyadic interaction across a range of behavioral and
biological targets is linked to the development of processes known to be disrupted in ADHD and ASD. Despite
these links, studies in ASD have largely examined individual behavior during interactions, with only a handful
reporting on dyadic aspects. This is a critical gap, since the temporal structure of the synchronous component
of an interaction may represent an emergent property distinct from each individual’s contributions. No studies
have examined these questions in infants at risk for ADHD, but research in older youth has documented reduced
synchrony. Moreover, despite shared risks, nothing is known about shared vs. distinct influences of early dyadic
synchrony on ADHD vs. ASD symptom development, nor the influence on outcomes beyond the preschool
period. Middle childhood represents a key transition period characterized by the emergence of relevant clinical
phenotypes like ADHD and dramatic changes in domains influenced by parent-infant synchrony, including social
competence and self-regulation, making longer-term follow-up of these samples critical not only for the infants
who develop ADHD or ASD, but also for the large number of at-risk infants who do not, but who experience
subthreshold symptoms and other challenges as they age. This project will leverage 3 prospective longitudinal
cohorts of infants (n=326) recruited through the PI’s prior NIMH-funded studies, previously seen at 6/9, 12, 18,
24, and 36 months of age, extending follow-up to ages 6-10 years. These samples are enriched for a range of
phenotypic variation, having over-enrolled infants with a family history of ADHD or ASD, and infants at low risk.
Middle childhood outcomes will be carefully characterized across key clinical, social, and self-regulatory domains
(Aim 1). Previously collected videos of naturalistic parent-infant play will be subjected to novel automated
methods to detect behaviors relevant to RDoC constructs of cognitive systems, negative/positive valence
systems, and social processes, allowing examination of the influence of early-life dyadic synchrony on middle
childhood outcomes (Aim 2). Aim 3 explores moderators and mediators of these associations, including
capitalizing on the genetically-informed design to test the degree to which early-life dyadic synchrony moderates
genetic risk for ADHD and ASD. Results could help to understand etiological links between ADHD and ASD,
elucidate protective and modifiable risk factors, and identify targets for caregiver-mediated, transdiagnostic
prevention and early interventions that have broad effects across the lifespan.

Public health relevance
PROJECT NARRATIVE This study is focused on the longer-term development of infants at elevated genetic risk for ADHD and autism, with a particular focus on autism and ADHD symptoms, social competence, and self-regulation. The study will evaluate the influence of early-life dyadic synchrony on these middle childhood outcomes, taking advantage of the genetically-informed design. The goal is that this research could clarify links between autism and ADHD, elucidate modifiable risk factors, and inform development of transdiagnostic caregiver-mediated early interventions to lessen challenges often experienced by infants at risk for autism and ADHD as they age.